Systems analysis and improvement approach to improve integration of HIV prevention and treatment services

East and Southern Africa is home to 6.2% of the world’s population but includes 54% of all people living with
HIV (PLWH). In this region, three out of five PLWH are women, and there is a particularly high burden of HIV
amongst adolescent girls and young women (AGYW). Over half of African women use family planning (FP)
services. Integration of HIV prevention and treatment with FP services holds promise for supporting progress
toward the UNAIDS 95-95-95 targets for testing, treatment, and prevention. Nonetheless, integration of even
basic HIV prevention and treatment services into FP clinics remains low and how best to integrate these
services is still unknown. In a previous trial, the Systems Analysis and Improvement Approach (SAIA), was an
effective implementation strategy for improving HIV counseling and testing in a small selection of FP clinics in
Mombasa County, Kenya when delivered by research staff. SAIA incorporates a cascade analysis tool,
sequential process flow mapping, and cycles of micro-intervention development, implementation, and
assessment to improve a care cascade. More data is needed to understand if SAIA is effective for also
improving linkage to HIV care and screening and linkage to pre-exposure prophylaxis (PrEP) in FP clinics
when SAIA is delivered at scale by Kenyan public health workforce. The first objective of this study is to
conduct a cluster-randomized trial evaluating the effectiveness of SAIA versus control (usual procedures with
no specific intervention) for increasing HIV counseling, testing, linkage to HIV care, and screening and linkage
to PrEP in new FP clients and new and returning AGYW clients. There will be a particular focus on the HIV
prevention and treatment of AGYW in this study and any AGYW presenting for FP care will be prioritized.
Quantitative and qualitative data will be analyzed using the RE-AIM framework to evaluate the program’s
Reach, Effectiveness, Adoption, Implementation, and Maintenance. To understand how SAIA could be
integrated into national Ministry of Health policies and programs, activity-based costing will be conducted to
estimate the budget and program impacts of SAIA, scaled to a County level, from a Ministry of Health
perspective. It is hypothesized that compared to control, SAIA will be effective at increasing HIV counseling,
HIV testing, linkage to HIV care, and screening and linkage to PrEP for new FP clients and all new and
returning AGYW FP clients when delivered at scale by Kenyan public health staff. The implementation
evaluation, costing, and budget impact analysis will establish a road map for national-level implementation,
positioning Kenya as a global leader in integrating FP/HIV services.

Public health relevance
Integrating HIV treatment and prevention into family planning clinics offers a promising approach to reach reproductive aged women, including the priority population of adolescent girls and young women, who may be otherwise missed in a siloed healthcare system. This study will provide necessary information regarding SAIA’s reach, effectiveness, adoption, implementation and maintenance in the real world setting when implemented at scale by Kenyan public health staff to increase HIV counseling, HIV testing, linkage to HIV care, and screening and linkage to PrEP as well as SAIA’s effect on the County budget. SAIA has the potential to dramatically improve women’s sexual and reproductive health by improving HIV prevention and treatment services for women in Kenyan family planning clinics.